Microbial activators of host satiety

PROJECT SUMMARY/ABSTRACT
Although a cause-and-effect relationship between the microbiome and obesity—and its related metabolic
diseases—has been identified for almost 20 years, there are still no obesity therapies targeting or utilizing the
microbiome. This is due, in part, to a lack of mechanistic understanding. The long-term goal is to delineate the
mechanisms commensal organisms use to benefit host metabolic regulation and to develop new therapeutics
targeting those pathways. We and other groups have identified Blautia species as candidate commensals that
supports metabolic and mucosal health. Our prior studies of human subjects demonstrated an association
between low Blautia levels and obesity, loss of control eating, and greater fat ingestion in a buffet-meal setting.
The overall objective of this proposal is to determine how Blautia, and its metabolites activate signaling events
within the gut epithelium. Our central hypothesis, based on our prior studies, is that acyl amines synthesized by
Blautia species activate enteroendocrine cell (EEC) production of GLP-1 and PYY, which benefit host
metabolism, and GLP-2, which benefits the structure and function of the gut mucosa. The rationale for this project
is that a fundamental understanding of how Blautia benefits host metabolism and epithelial health will allow us
to harness Blautia, its metabolites and other beneficial commensals to treat obesity and related disorders. The
central hypothesis will be tested via two specific aims: 1.) Identify the synthetic processes and microbial products
that augment EEC activation by Blautia; and 2.) Delineate the mucosal and metabolic effects of Blautia acyl
amine production in vivo. Under the first aim, we will use a CRISPRi system to perform genome editing in Blautia
wexlerae—suppressing the expression of native genes in this key commensal organism has not yet been done.
To define the bacterium’s genetic requirements for synthesizing EEC-activating acyl amines—as measured by
LC-MS—we will knock down candidate acyl transferase genes. We will also screen a library of microbial
metabolites for molecules that synergize with acyl amines to boost EEC activation. This will be done high-
throughput in a cell culture model of EECs and validated in EEC-containing human organoids. The second aim
will delineate the physiologic consequences of B. wexlerae acyl amine production in mice. Here, we will utilize
our newly established model of B. wexlerae colonization in germ-free mice, which we have shown increases acyl
amine production in the gut by 5-10-fold. We will determine the effects of B. wexlerae on glycemic control, insulin
sensitivity, food intake, weight and epithelial proliferation. The work is technically innovative in that it will uniquely
combine new bacteriological methods, microbial metabolite analyses, and high-throughput screening of host
phenotypes to maximize the likelihood of discovering new host-microbe interactions. The proposed studies are
scientifically innovative because they will test a series of mechanism-based hypotheses that focus on advancing
our understanding of how Blautia influences the host. Ultimately, this more precise understanding will open new
horizons for utilizing Blautia and other microbes for clinical applications.

Public health relevance
PROJECT NARRATIVE Obesity remains one of the great pediatric health challenges of our time, with over 30% of children and adolescents falling into the overweight or obesity categories, putting them at risk for metabolic syndrome, cardiovascular disease and early death. The most successful therapies for obesity target gut peptide hormones produced by enteroendocrine cells (EECs), and emerging evidence points to metabolites made by gut microbes as potent activators of EECs. Our proposal seeks to identify microbes that activate EECs and to delineate how they might do so, which could provide the basis for new microbiome therapeutics for obesity and its related diseases.